Glutamate Transport into Synaptic Vesicles

The quantal nature of synaptic transmission depends on the transport of neurotransmitter into synaptic
vesicles (SVs), an activity driven by a H+ electrochemical gradient (∆µH+). In contrast to relatively stable ionic
gradients across the plasma membrane, ∆µH+ and other ions including Cl- fluctuate with the exo- and endocytosis
of SVs. Vesicle filling requires coordination with these changing conditions and hence regulation of transport.
In contrast to the SV uptake of most transmitters that relies primarily on the chemical component of ∆µH+
(∆pH), uptake of the principal excitatory transmitter glutamate depends predominantly on membrane potential.
The vesicular glutamate transporters (VGLUTs) also exhibit unusual properties, including allosteric regulation by
lumenal H+, cytosolic and lumenal Cl- and an associated Cl- conductance. We hypothesize that these
mechanisms coordinate glutamate flux with different steps in the exo- and endocytic recycling of synaptic
vesicles. The long-term objective of this proposal is to understand how these properties of the VGLUTs contribute
to excitatory neurotransmission. The strategy is to determine how these mechanisms regulate VGLUT activity,
and use this information to characterize their physiological role. This program takes advantage of our previous
work identifying these regulatory mechanisms, assays we developed to study them, recent structural information
and VGLUT knockout neurons that we can use to test rescue by mutants.
Aim 1: Elucidate the mechanism and physiological role of pH in vesicular glutamate transport. The
requirement for allosteric activation of the VGLUTs by lumenal H+ suggests a mechanism to prevent tonic efflux
of glutamate across the plasma membrane that would degrade the quantal signal. We recently identified a single
residue that confers the pH requirement of vesicular glutamate transport. We will now use this information to
determine how pH regulates glutamate transport and how this regulation influences excitatory transmission.
Aim 2: Determine how Cl- allosterically regulates vesicular glutamate transport. We recently found that an
extensive cytoplasmic interaction network influences the allosteric regulation by lumenal pH on the other side of
the SV membrane, suggesting that the alternating access involved in glutamate transport depends on the
balance in strength between cytoplasmic and lumenal gates. We hypothesize that Cl- also affects the two gates,
either directly or indirectly. We will thus determine how the cytoplasmic interaction network and lumenal residues
contribute to allosteric regulation of glutamate flux by cytoplasmic and lumenal Cl-.
Aim 3: Aim 3: Determine how lumenal Cl- affects glutamate storage and release. Removal of extracellular
Cl- prevents recovery from the synaptic depression that normally follows strong stimulation. To determine
whether this reflects a requirement for the efflux of lumenal Cl- mediated by a VGLUT-associated conductance,
we will rescue VGLUT1/2 double knockouts with mutants lacking the conductance, and monitor the effects on
glutamate release and SV pH.

Public health relevance
Project Narrative Release of the excitatory neurotransmitter glutamate depends on its storage inside synaptic vesicles. However, the ions important for glutamate uptake fluctuate dramatically as synaptic vesicles undergo exo- and endocytosis. We will now determine how the unusual properties of vesicular glutamate transport that we have identified serve to coordinate vesicle filling with events in the synaptic vesicle cycle.